Re-engineering for Accurate, Timely, and Communicated Diagnosis of Cardiovascular Disease in Women (DREAM Lab)

PROJECT SUMMARY
Cardiovascular disease (CVD), including heart disease and stroke, is our nation’s costliest and most
devastating chronic disease, and is fraught with diagnostic error. Despite ground-breaking progress in
addressing CVD through years of clinical and biological research, errors in the diagnosis, treatment,
and communication of CVD disproportionately impact women. Women are nearly twice as likely as men
to receive the wrong initial diagnosis following a heart attack and 30% more likely to have stroke symptoms
misdiagnosed in the emergency department (ED). Even when accurately diagnosed, women are less likely to
receive timely evidence-based treatments. The National Academy of Medicine report Improving Diagnosis in
Healthcare defined diagnostic error as “the failure to (a) establish an accurate and timely explanation of the
patient’s health problem(s) or (b) communicate that explanation to the patient”. On every dimension of that
definition, women with CVD fare worse than men and the combination of gender and race is even more lethal.
Transdisciplinary teams leveraging systems engineering, using novel tactics and rigorous evaluation
techniques are positioned to successfully mitigate this complex problem. Our Patient Safety Learning
Laboratory (PSLL) will address Re-engineering for Accurate, Timely, and Communicated Diagnosis of
Cardiovascular Diseases in Women: the (DREAM) Lab. We will apply a mixed-methods systems
engineering approach to understand the complex interplay of factors contributing to CVD diagnostic error in
women in the ambulatory care setting, and co-design and evaluate adaptive solutions. Our population health
approach will evaluate factors including but not limited to the physical environment, social and economic
determinants, clinical care, health information technology, and health behaviors. The DREAM Lab will:
a. Identify the contributing factors leading to diagnostic errors and inappropriate clinical management of CVD
in women and develop pragmatic performance and improvement measures.
b. Propose, prioritize, and co-design human-centered solutions to mitigate diagnostic risk.
c. Evaluate the structure, process, and outcome effects of human-centered solutions on CVD diagnosis,
clinical management, and communication in simulated and clinical environments.
The proposed work sets up a clear pathway toward clinical implementation. By systematically evaluating
human-centered solutions in a simulated environment with input from practicing clinicians and patients as the
end-users, followed by pilot testing promising solutions in the clinical environment, we provide operationally
ready solutions. The DREAM Lab’s impact, particularly for vulnerable patients disproportionately impacted by
heart attacks and stroke, has the potential to influence broad-scale change and disrupt the status-quo, yielding
significant improvements in care cost, quality, experience, and value for women and the healthcare system.

Public health relevance
PROJECT NARRATIVE Cardiovascular disease (CVD), including heart disease and stroke, is the leading cause of death and disability for women in the U.S, and costs nearly a billion dollars a day in associated medical expenses. Women experience errors in the diagnosis, treatment, and communication of CVD far more often than men. This project will work with patients, doctors, and researchers to improve the diagnosis and treatment of CVD in women, improving outcomes and reducing costs.